Genetic determinants of 4D genome folding in human cardiac development

PROJECT SUMMARY
A major unanswered question is how chromatin topology coordinates human development and cellular
differentiation, and how genome folding is differentially regulated in human disease. It is thought that three-
dimensional (3D) chromatin organization is driven by transcriptional regulators, but fundamental mechanisms
of this regulation as it relates to disease-relevant human cells have not been well explored. We propose to
elucidate the temporally dynamic 3D nucleome (4DN) that underlies human cardiac differentiation, its
molecular underpinnings, and the impact of mutations that underly defective 4DN organization in human
congenital heart disease (CHD). CHDs are the most common birth defect and arise from abnormal heart
development. The genetic basis of CHD is largely mutations in genes encoding chromatin modifiers (e.g.
WDR5, KMT2D) and transcription factors (TFs, e.g. TBX5, GATA4), many of which also cause adult-onset
arrhythmias. The impact of CHD mutations on the 4DN has not been explored. We hypothesize that 3D
genome folding is highly regulated during cardiac differentiation and is impacted by disease-causing mutations
in transcriptional regulators and non-coding elements. We will use iPS cell models and machine learning to
elucidate dynamic 3D chromatin organization in human cardiomyocytes and endothelial cells during normal
and diseased cardiac differentiation. We propose 3 specific aims: Aim 1: Establish a kilobase-scale 4D map
of genome folding in human cardiomyocytes (CM) and endothelial cell (EC) differentiation. We will use
directed differentiation of human iPS cells towards the two major cell types of the developing heart: CMs and
ECs, and using microC across a fine time course of differentiation we will define at kilobase scale the 3D
organization of the genome, capturing the states of developmental intermediates and the final differentiated
cells. This aim will generate an essential integrated 4DN template for discovery in cardiac differentiation. In
Aim 2: we will Determine the regulatory and disease-related basis for cardiac 3D chromatin
organization. We will perform microC in iPS cell lines with CHD-associated mutations in transcriptional
regulators, differentiated into CMs and ECs. These findings will establish the degree to which CHD is caused
by abnormal genome folding and chromatin states, with important relevance to other human cardiovascular
diseases. Finally, Aim 3 will address High-throughput screening of millions of CHD and synthetic non-
coding mutations with a deep-learning model of dynamic genome folding. We will build a deep-learning
model predicting 3D chromatin contact frequencies across cardiac differentiation at kilobase-resolution. By
introducing thousands of CHD patient deletions and other non-coding mutations in silico, we will prioritize
variants likely to interact with transcriptional regulators to cause disease through disrupted genome folding.
Several candidates will be validated in engineered iPS cells differentiated into CMs and ECs. These results will
provide a novel platform for computational discovery of disease variant impact across diverse human diseases

Public health relevance
PROJECT NARRATIVE Congenital heart defects are present in 1-2 out of 100 births, and are caused by mutations in genes that may control the 3-dimensional organization of chromosomes. We will use human cellular models and Artificial Intelligence to understand how chromosome organization is controlled during heart development and altered by disease processes. This will reveal fundamental concepts of gene regulation and may lead to a better understanding congenital heart defects towards improving diagnosis and treatment.